An Interdisciplinary Training Program to Transform Graduate Education In Genetics and Genomics

PROJECT SUMMARY
Genetics is a foundational discipline central to biomedical research and clinical practice. Our mission is to train
geneticists for the 21st century. To achieve this goal, we have designed and implemented an interdisciplinary
training program to transform graduate education in genetics and genomics at the University of Minnesota. Our
Specific Aims are: (i) to provide students with rigorous and quantitative training in the fundamentals and state-
of-the-art advances in genetics, genomics, and computational biology; (ii) to leverage the many collaborative
research and educational strengths of our institution to provide new interdisciplinary student-centered graduate
training opportunities that transcend departmental and collegiate boundaries; and (iii) to generate a diverse
cohort of well-trained scientists able to integrate their broad skillset and their hunger for lifelong learning into
their work across a multitude of careers in the biomedical workforce. This program will enable trainees to
pursue many impactful career opportunities in academia, biotechnology, government, health care, or education
created by recent advancements in genetics and genomics, including careers in fields that are undergoing
rapid change, as well as careers in areas that do not presently exist or that are nascent. In recognition of the
fact that the geneticists of tomorrow must possess quantitative acumen, we have not only developed new
courses emphasizing bioinformatics and computational approaches, but we have also integrated these into our
training program through a major redesign of the graduate curriculum pursuant to evaluation by internal and
external review panels. In a sense, genetics and genomics are foundational fields that transcend and unify
multiple disciplines within the biological sciences because what sets living things apart from inanimate objects
is that all living things possess within them molecular blueprints for their construction, genomes. An impactful
aspect of this academic and research training program is that it seeks to transcend traditional departmental
boundaries by bringing together researchers from multiple disciplines within the biomedical sciences who
utilize genetic and genomic analyses in their research. In so doing, this training program seeks to promote
interdisciplinary research, foster collaborative team science, and implement individualized student-centered
educational and career development programs. Our training program includes 50 highly productive and
collaborative faculty from ten departments across five colleges at the University of Minnesota. We are seeking
support for six PhD trainees for two years each beginning in year two of their academic program, with funding
for year one provided by institutional funds. In addition to their thesis research, trainees will participate in
professional development programs aimed at promoting their transition into and long-term success in
biomedical science-related careers.

Public health relevance
NARRATIVE Genetics and genomics are foundational disciplines central to all biomedical research and its applications in clinical practice and precision medicine. The mission of the proposed predoctoral training program is to educate the next generation of scientists to advance biomedical research through the rigorous and creative application of genetic principles, genomic technologies, and rapidly evolving computational tools. Our objective is to train students to generate new knowledge and develop creative and impactful solutions to pressing problems affecting human health.